Integrated Host/Microbe (IHM) Metagenomics of the Lower Airway to Diagnose PediatricRespiratory Infections, Identify Etiologic Pathogens, and Predict Outcomes

SUMMARY
Lower respiratory tract infection (LRTI) leads to more deaths each year than any other type of infection and
disproportionately affects children. The past three years have seen record pediatric hospitalizations due to RSV,
influenza, and SARS-CoV-2, highlighting the burden of LRTI in this vulnerable demographic. LRTI remains
diagnostically challenging in children due to high rates of viral/bacterial co-infections, noninfectious syndromes
that mimic LRTI, frequent incidental pathogen carriage, and the limitations of existing clinical diagnostics. As a
result, accurate and timely LRTI diagnosis is difficult to achieve in pediatric critical care, leading to the
inappropriate use of empirical antibiotics, the emergence of resistant pathogens, and adverse patient outcomes.
Respiratory infections involve a dynamic relationship among three key features: pathogens, the airway
microbiome, and the host immune response. However, existing clinical tests rely primarily on pathogen detection,
limiting their diagnostic and prognostic utility. Our group has pioneered integrated host/microbe (IHM)
metagenomic next generation sequencing (mNGS) methods that enable accurate, culture-independent LRTI
diagnosis by simultaneously assessing all three key LRTI features from a single tracheal aspirate sample. Here,
we propose a prospective, multicenter cohort study of 400 critically ill children with acute respiratory failure
requiring mechanical ventilation that is designed to validate and extend the IHM diagnostic we developed.
Aim 1 will independently validate the performance of our existing IHM LRTI diagnostic classifier in
distinguishing LRTI from non-infectious acute respiratory conditions and in identifying likely etiologic pathogens.
Aim 2 will develop a novel host gene expression classifier specifically for bacterial LRTI rule-out, which would
reduce unnecessary antibiotic use in a principled manner. For both Aims 1 and 2, we will additionally develop
parsimonious host-based PCR versions of the classifiers for rapid, point-of-care LRTI diagnosis and bacterial
LRTI rule-out where mNGS capacity is unavailable. Finally, Aim 3 will develop novel IHM classifiers to predict
LRTI outcomes, including prolonged mechanical ventilation and persistent acute respiratory distress syndrome
(ARDS), which can facilitate prioritization of resources and intensive interventions to the highest-risk patients.
This study promises to address the unmet need for accurate molecular LRTI diagnostics that detect emerging
pathogens, enable judicious antimicrobial treatment, and predict outcomes in critically ill children. Our
multidisciplinary team of translational scientists with experience in innovative metagenomic approaches is well-
positioned to accomplish the study goals. The results of this study will directly inform the design of a future clinical
trial evaluating the impact of IHM diagnostics on clinical management and patient outcomes.

Public health relevance
NARRATIVE Lower respiratory tract infections (LRTIs) are the leading cause of infectious disease-related death in children worldwide, and efforts to improve LRTI outcomes are challenged by a lack of diagnostic tests capable of detecting known and novel respiratory pathogens and reliably informing targeted antimicrobial therapy decisions. We will develop and validate novel metagenomic sequencing-based tests for LRTI diagnosis, bacterial infection rule-out, and outcome prognosis using an approach that integrates the detection of host transcriptional biomarkers, microbial pathogens, and the lung microbiome. We will achieve these aims by studying a prospective, multicenter cohort of critically ill children with acute respiratory failure, and our findings will be used to design a future randomized controlled trial to evaluate the impact of our novel diagnostic and prognostic tests.